Community Engagement Core

Abstract: The premise of the Community Engagement Core (CEC) is to advance the science of community
engagement toward increasing African American (AA) and Hispanic communities’ participation in genomic
research. Specifically, the CEC will implement a ‘community-centered’ multi-level and multi-domain participant-
centric strategy to engage AA and Hispanic communities a) in the development of culturally appropriate
interventions for genomic education; b) to promote their recruitment and retention in genomics research; and c)
facilitate the translations and dissemination of study results. Advances in genomics have increased our
understanding of the unique interplay between genetics, environment, behavior, and disease, which has led to
the advancement of clinical-trial matching and precision health (medicine and prevention). However, these
scientific advances are hampered by the inadequate representation of AA and Latinx populations in genomic
research studies; thus, it is paramount to identify effective engagement strategies to increase genomic
knowledge and research participation among AA and Latinx populations. To achieve the specific aims, the CEC
will train an existing cadre of lay community navigators as genomic navigators (GNs) to deliver relevant education
and provide navigation services, to two populations historically underrepresented in genomic research.
Collaborate with Administrative Core to establish Community Advisory Board; Implement quarterly community
education events calendar; Elucidate pre-conception exposures of concern for project 1; Support translation of
Study results for dissemination; Collaborate with Workforce Development Core in early education pipeline
activities and participate in the presentation of Study findings to community stakeholders.

Public health relevance
SPECIFIC AIMS: COMMUNITY ENGAGEMENT CORE The premise of the Community Engagement Core (CEC) is to advance the science of community engagement toward increasing African American (AA) and Hispanic communities’ participation in genomic research. Specifically, the CEC will implement a ‘community-centered’ multi-level and multi-domain participant-centric strategy to engage AA and Hispanic communities a) in the development of culturally appropriate interventions for genomic education; b) to promote their recruitment and retention in genomics research; and c) facilitate the translations and dissemination of study results. Advances in genomics have increased our understanding of the unique interplay between genetics, environment, behavior, and disease, which has led to the advancement of clinical-trial matching and precision health (medicine and prevention). However, these scientific advances are hampered by the inadequate representation of AA and Hispanic populations in genomic research studies; thus, it is paramount to identify effective engagement strategies to increase genomic knowledge and research participation among AA and Hispanic populations. The inclusion of these populations will help us understand the genomic contributions to certain diseases, increase representation of these groups in genomic research, thereby reducing health disparities and advancing health equity. We will train an existing cadre of lay community navigators as genomic navigators (GNs) to deliver relevant education and provide navigation services, to two populations historically underrepresented in genomic research. We seek to standardize the genomic education provided to AA and Hispanic participants by equipping each GN with evidence-based educational resources on genomics and research participation developed by the National Human Genome Institute (NHGRI). Based on previous work, we will culturally adapt the educational materials to multiple media content (audio and video) delivered via mobile tablet technology. It is expected the GNs will provide education and logistical support to AAs and Hispanics interested in participating in genomic research in rural and urban areas. Of note, the GNs will also address AA and Hispanic beliefs, values, attitudes, and preferences related to participation in research. The CEC will deploy evidence-based strategies and tactics for engaging all elements of our defined community. Historically, we have had success in enrolling and retaining AA and Hispanic members of our community by ensuring that they can trust our processes to protect their privacy and return value for their participation. Value in this instance goes beyond a transactional return of value to a more sustained return of value based on a deep understanding of community needs. The engagement framework incorporates the right people (roles), processes and platforms to ensure reproducible results. The Specific Aims guiding the Core activities are: Aim 1: Enhance sustainable partnerships with statewide community- and faith-based organizations through a Community Advisory Board to facilitate a series of structured educational sessions (townhalls) to address bioethics concerns and issues of trust relative to AA and Hispanics participation in genomic research. Aim 2: Implement multi-level engagement strategies, Genomic Navigators, to promote genomics research education and awareness, recruitment, and retention of study participants, and address social determinants of health. Aim 3: Evaluation of Core activities and dissemination of information to diverse stakeholders including Community members, Partner organizations, and relevant Service organizations or Policymakers, as well as the scientific community. Significance. The activities outlined in this proposal are congruent with the strategies in the Diversity Centers for Genome Research RFA listed for the Community Engagement Core: Applicants should describe strategies for recruiting and maintaining long-term relationships with communities to enhance genomic knowledge, integration with Center research projects, promotion of participation in genomics research and recruitment and retention of study participants and dissemination of information and data generated by the Center. Despite NIH mandates for adequate representation of all populations in research, AA and Hispanic populations remain largely under-represented, particularly in genomic research and clinical trials. Having a community advisory board (CAB) guided multi-level approach will lead to increased awareness, opportunity, and participation in genomic research among a diverse population of AAs and Hispanics.